Neuroinflammatory GeroMiRs and Alcohol: Defining Mechanisms of ADRD

Project Summary
The proposed project will examine the mechanisms by which ethanol-related dementia is greater in older
subjects. We live in a rapidly aging society which as been designed the “Silver Tsunami” of individuals aged 65
or older (i.e. advanced age, aged). Accordingly, the number of chronic diseases, including age-related dementia,
is increasing and 90% of dementia cases are sporadic and driven by environmental cues. Approximately forty
percent of aged adults consume alcohol and the prevalence of binge drinking in older adults is on the rise.
Despite these trends, there are significant gaps in knowledge related to the health impacts of alcohol use and
misuse in individuals with advanced age; this proposal aims to fill these gaps in knowledge. Chronic inflammation
is a critical driving factor of neurodegeneration and cognitive decline and is independently increased by both age
and alcohol. We and others hypothesize that heightened inflammatory responses predisposing older individuals
to alcohol-induced end organ damage is at least partly attributed to the effects of low-grade chronic inflammation
that increases with age, termed "inflamm-aging." Because both inflamm-aging and alcohol independently and
negatively impact the resident macrophages in the brain, the microglia, is our working hypothesis that relative to
young, older subjects have heightened inflammatory responses that fail to resolve, leading to excessive systemic
and neuroinflammation and damage to critical organs like the brain. Accordingly, the associated hippocampal
damage will drive accelerated cognitive decline and early onset dementia. In this proposal, we will explore how
age and alcohol impact the expression of regulatory miRNAs in microglia, and determine if these changes result
as 1) a direct effect of ethanol toxicity and 2) an indirect effect via the gut-brain axis. To investigate the role of
alcohol and age on neuroinflammatory responses, in Aim1 we will make use of a novel mouse model of binge
ethanol exposure to establish the neurotoxic effects of alcohol on disease progression and early onset dementia
in aged mice. We will also make use of primary microglia from young and aged mice and profile the
microRNA/mRNA landscape in response to in vivo ethanol exposure. In Aim 2, we will examine the role of
miR223 as an important regulatory factor modulating inflammatory responses in microglia and will establish if
gene therapy replacement of miR223 will prevent ethanol-induced neuroinflammation and dementia in aged
mice. Finally, Aim 3 will focus on the gut-brain axis and will be able, for the first time, to monitor age-related shifts
in the microbiome and determine if age-related intestinal dysbiosis can predispose neuroinflammatory responses
to alcohol, via elevated systemic inflammation and changes to regulatory miRNAs in microglia. These studies
will expand our understanding of how components of “inflamm-aging” lead to dysregulated miRNA profiles in
immunomodulatory components in the brain, which are critical sensitizing factors during bouts of ethanol
exposure and withdrawal. Importantly, this work may highlight/discover novel targets leading to the development
of therapeutic strategies to improve or prevent early onset dementia in patients of all ages.

Public health relevance
PROJECT NARRATIVE We live in a rapidly aging society and in the United States, the population of individuals over the age of 65 is expected to reach 90 million people by 2050. Approximately 40% of elderly people consume alcohol which is associated with accelerated cognitive decline. To goal of this project is to identify specific perturbations in host innate immunity, including regulatory microRNAs, caused by alcohol misuse during aging, to provide a foundation for future clinical interventions to prevent neuroinflammation and early onset dementia in patients of all ages.